Module 2: Histology and Imaging

The histology and imaging module allows investigators to understand visual function and disease at a
cellular/subcellular level. It offers outstanding technical expertise, training and state-of-the-art instrumentation
needed to conduct rigorous histologic/morphologic studies and image analyses. The expertise and
instrumentation available in this module far exceed resources of individual investigators’ laboratories. Histologic
services offered by a highly skilled technician include guidance in isolation/orientation/fixation/embedding of
ocular tissues (or cells), routine and specialized sectioning and staining, as well as training for immunodetection
studies. A PhD level scientist with extensive expertise in the visual system is available for electron microscopic
studies permitting ultrastructural analysis of ocular tissue as well as protein-protein interactions at the subcellular
level. This module features state-of-the-art imaging instrumentation including access to super resolution
microscopy, multiple confocal microscopes (upright, inverted, multiphoton) and laser capture microdissection. A
highly skilled PhD level scientist, with excellent background in vision research, oversees these instruments and
will assist investigators in generating high quality, reliable, reproducible data. She will assist users with
production of publication-quality images. The module will provide technical expertise and instrumentation to
achieve the following three aims: Aim 1: Provide core investigators with expertise for isolation and orientation of
ocular tissues/cells, appropriate histologic processing to meet specific experimental needs, guidance in
immunodetection of proteins, including EM immunodetection methods. Aim 2: Provide expert technical
assistance and training in the use of laser scanning confocal microscopy, multiphoton microscopy, super
resolution microscopy and laser capture microdissection. Aim 3: Provide expert technical assistance in the use
of electron microscopy and image capture. Support of this module will provide resources needed by nearly all of
our vision researchers to engage in high impact research and discovery for patients suffering from blindness and
visual disorders.